REGULATION AND FUNCTION OF ULTRADIAN INSULIN AND SECRETION PULSES

The overall objective of this research is to determine the in vivo regulatory and functional characteristics of the ultradian insulin secretory pulses in normal subjects.